Core-011

ABSTRACT
The University of Chicago Medicine Comprehensive Cancer Center (UCCCC) Transgenic Mouse/Embryonic
Stem Cell Facility (TMESCF) provides comprehensive genetic engineering services to alter the genome of the
laboratory mouse. UCCCC investigators develop and exploit a variety of different mouse models of cancer to
understand the etiology, progression and treatment of cancer as a disease. These approaches are particularly
important to increase our understanding of the role of the immune system in tumorigenesis, and to develop
increased knowledge of the factors affecting tumor metastasis, as well as other aspects of cancer that are best
modeled in the whole animal. The Facility provides specialized technology to generate genetically engineered
mice through the microinjection of mouse embryos and through the use of gene targeting/editing in embryonic
stem (ES) cells. With the advent of new genome editing approaches, the demand for these services is greater
than ever. In particular, demand from our faculty for CRISPR/Cas9 genome editing and TARGATT sitedirected transgenics has grown exponentially over the past few years following our successful introduction of
these technologies in 2013. The Transgenic Mouse/Embryonic Stem Cell Facility allows our investigators to
develop mouse models of cancer at the cutting-edge of technology, with CRISPR/Cas9, for example, allowing
us to introduce tags, specific deletions/mutations, and other genetic changes more rapidly and on a broader
scale than in the past. Having such a dedicated Facility also allows our investigators to remain competitive in
this rapidly evolving field, obtain much valued advice on the types of models that can be developed, and learn
from the various new and innovative approaches being tested in the TMESCF.